Mechanisms of Lymphatic Metastasis in Pancreatic Ductal Adenocarcinoma

ABSTRACT
Distant metastasis is the primary cause of cancer-related death and is generally preceded by metastasis to
the lymph node (LN). Since lymph nodes serve as staging grounds for anti-tumor immunity, their high
susceptibility to metastatic colonization has been considered a paradox. To date, it has been thought that for
tumor cells to survive in the draining lymph node, it must first be preconditioned by extrinsic, tumor-derived,
factors towards a state of immune-suppression. Whether intrinsic qualities of the lymph node may also impede
its immune response to metastasizing tumor cells is not known. My thesis work to date has identified an
intrinsic basis for early lymph node metastasis, independent of preconditioning, linked to the lymph node’s
large regulatory T cell (Treg) population. Using murine cancer cell lines that express an antigen, we find that
tumor-specific CD8 T cells exhibit markedly lower cytotoxicity in lymph nodes than in circulating blood. T cell
depletion greatly enhanced hematogenous metastasis to the lungs but not lymphatic metastasis to regional
lymph nodes. Direct injection of parental tumor cells into the lymph node and blood formed tumors at a similar
rate in the lymph node and lungs, respectively, but forced expression of antigen conferred a marked growth
advantage following intra-lymph node injection. This advantage was dependent upon regulatory T cells, which
locally suppressed the cytotoxicity of tumor-specific CD8 T cells in the lymph node to permit tumor growth.
Based on my preliminary findings, depleting Tregs is an attractive therapeutic strategy for treating LN
metastasis. However, systemic and continuous depletion of Tregs leads to autoimmunity and eventual death.
In Aim 1 I will Investigate transient, single LN Treg depletion as a therapeutic strategy to treat LN metastasis.
As LNs promote anti-tumor immune responses by facilitating priming events, an accumulation of tumor
cells in the LN could represent an opportunity for increased antigen uptake and priming. Consistently, my
preliminary data suggests that metastatic LNs have many more antigen-carrying DCs than non-metastatic
draining LNs. However, the antigen-carrying DCs in tumor-bearing LNs are significantly suppressed,
expressing very low levels of co-stimulatory molecules. As Tregs also accumulate during LN metastasis, I
hypothesize that Tregs prevent effective anti-tumor priming by suppressing co-stimulatory molecule expression
on tumor-antigen carrying cDC1s. In Aim 2 I will determine whether Tregs suppress anti-tumor CD8 T cell
priming in the lymph node by suppressing co-stimulatory molecule expression on tumor antigen-carrying DCs
or by preventing antigen stimulation. I hypothesize that transient depletion of regulatory T cells in a single
metastatic LN will restore anti-tumor CD8, priming and cytotoxicity and effectively eradicate LN metastasis.

Public health relevance
Project Narrative Lymph nodes are paradoxically the first site of metastasis in many human cancers despite being immune organs that coordinate anti-tumor immunity. My preliminary data identifies local suppression of CD8 T cells in the lymph node by regulatory T cells (Tregs) as an intrinsic, immunologic, mechanism underlying the lymph node’s susceptibility to metastatic colonization. I will further test the mechanisms by which regulatory T cells facilitate LN metastasis and test a novel therapeutic strategy of for preventing LN metastasis by local, transient, Treg depletion.